MUFA-SIRT1 signaling as a central node regulating healthspan

Diet is a major regulator of most if not all aging-related diseases. The Mediterranean Diet is widely regarded
as the gold standard of diets due to its ability to reduce a wide range of aging-related diseases resulting in
improved healthspan. While numerous components of the Mediterranean Diet likely contribute to its health
benefits, extra virgin olive oil has emerged as a major constituent underlying these effects. Indeed, both
epidemiological and interventional studies have linked extra virgin olive oil consumption to improved health
benefits including reductions in cognitive decline and neurodegenerative diseases. Extra virgin olive oil is
largely comprised of oil enriched in monounsaturated fatty acids (MUFA) as well as a diverse class of phenolic
compounds. Interestingly, both MUFAs and the many phenols found in extra virgin olive oil have been shown
in pre-clinical and clinical trials to have positive effects on cognition and in the prevention of Alzheimer’s
Disease and related dementias. Our laboratory has found the MUFAs are allosteric activators of sirtuin 1
(SIRT1), a key nutrient sensing protein that regulates a plethora of pathways controlling aging-related
pathologies. Numerous phenols, including some found in extra virgin olive oil, also can activate SIRT1 to
improve aging related outcomes and, as we have shown, these small molecules likely activate SIRT1 through
the same mechanism as MUFAs. Thus, deciphering the health benefits of MUFAs vs non-lipid components
in olive oil, and the extent to which SIRT1 allosteric activation mediates these effects, would greatly advance
our understanding of the Mediterranean Diet, the health benefits of olive oil, and SIRT1 biology. In addition,
MUFA signaling to SIRT1 occurs upon conditions that stimulate lipolysis such as fasting or caloric restriction
suggesting that diet composition and eating patterns are co-dependent. Based upon these data, we
hypothesize that MUFAs and extra virgin olive oil phenols will prevent declines in cognition and neurological
impairments via SIRT1 activation and will modulate the effects of caloric restriction. To test our hypothesis,
we will conduct the following two aims. 1) To test the effects of extra virgin olive oil MUFAs and phenols
signaling via SIRT1 on aging-related neurodegeneration. In this aim, we will feed wild-type or SIRT1 E222K
mice, which lack responsiveness to SIRT1 allosteric activators, diets enriched in olive oil with high or low
phenolic content and comprehensively characterize neurological function and cognition. 2) To determine
impact of olive oil and caloric restriction alone or in combination on neurodegeneration. We will feed middle-
aged mice diets with low or high MUFA along under ad libitum or caloric restriction conditions to determine if
the interaction between these two dietary interventions impacts cognition and neural function. We expect
these studies to advance our understanding into how dietary lipids and caloric restriction impact the aging
brain, which will help define new mechanisms underlying neurodegenerative diseases and open new
therapeutic avenues targeting lipid metabolism.

Public health relevance
The proposed studies will advance our understanding into the underlying biology linking dietary factors to declines in brain function and the development of Alzheimer’s Disease and related dementias. The data gleaned from these studies will help advance therapeutic or nutritional avenues to alleviate neurodegenerative diseases resulting in a direct, positive impact on human health.